Mass Spectrometric Analytical Collaborations with Members of the Carcinogenesis and Chemoprevention Program of the University of Minnesota Masonic Cancer Center

Project Summary
I am the Director of the Analytical Biochemistry Shared Resource of the University of Minnesota's Masonic Cancer Center
(MCC), a National Cancer Institute-designated Comprehensive Cancer Center. The shared resource has emerged as a
leading academic mass spectrometry laboratory, acting as an extension of the MCC's Carcinogenesis and Chemoprevention
Program (CCP), and providing critical analytical services to CCP members who account for a large majority of the analysis
performed in the facility. There are currently 16 NCI-funded projects involving nine CCP members who use the mass
spectrometry facility. The integration of the Analytical Biochemistry Shared Resource and the CCP is such that the mass
spectrometry laboratory staff, through extensive training and consultation with group members and collaboration with
principal investigators, functions as the analytical component of many of the research groups. The scientific goals of the
CCP are to understand the chemical and molecular mechanisms of carcinogenesis. The relevance of this knowledge to
public health is through the ability to use it to develop and evaluate practical methods for cancer prevention.
I am an integral part of the CCP through extensive consultation and collaboration with the members regarding their mass
spectrometry-based analyses, as well as by working very closely with their research groups. I have daily interactions with
the investigators and routinely attend laboratory group meetings, contribute to writing manuscripts, and participate in the
CCP Seminar Series and the Translational Biomarkers Working Group. The need for my consultation and collaboration
with members of the CCP regarding advanced analytical measurement, as well as day-to-day training and oversight of
members of their research groups, has been growing steadily with the increasing analytical capabilities of the laboratory
and increasing dependency of the users on mass spectrometric analysis to advance their research. There is an ongoing need
to continue to advance the analytical capabilities of the facility as the field of biomedical mass spectrometry continues to
grow and the research goals of the program members evolve. An external source of financial support would give me the
independence and freedom to focus on collaborative efforts with the NCI-funded members of the CCP to provide them with
the guidance and knowledge to harness the advanced analytical capabilities of the mass spectrometry laboratory.

Public health relevance
Project Narrative This project will provide researchers studying carcinogenesis and chemoprevention with advanced analytical tools to advance their research goals. It will help them to advance the understand of how cancer is initiated and use this information to develop strategies for cancer prevention and/or treatment of cancer.